Naturally occurring canine myxomatous mitral valve disease as a large animal model for human non-syndromic mitral valve prolapse

PROJECT SUMMARY
Non-syndromic mitral valve prolapse (MVP), a common valvular heart disease affecting 2-3% of the human
population, can lead to mitral regurgitation, cardiac dysfunction, congestive heart failure and even sudden death.
Given the lack of medical therapeutics to manage this disease, MVP is currently treated by surgical intervention.
Development of effective strategies for medical management has been hindered by an incomplete understanding
of disease pathophysiology, specifically regarding factors that drive differentiation of valve interstitial cells (VICs)
from fibroblast- to myofibroblast-like cells, resulting in myxomatous pathology. Furthermore, genetically modified
animal models that faithfully recapitulate human MVP pathology are unavailable, in part due to the relative
complexity of genetic factors found to be associated with disease predisposition. Interestingly, MVP (also termed
myxomatous mitral valve degeneration) occurs frequently in dogs with an estimated incidence of greater than
50%. Previous comparisons of canine and human MVP demonstrated that they share several key histopathologic
features suggesting that the spontaneous dog disease may represent a good translational model. Using canine
MVP as a template, I have been investigating the potential role of extracellular vesicles (EVs) and miRNAs in
driving the fibroblast to myoblast switch. EVs are membrane-bound cell-derived particles used for inter-cell
signaling through the transfer of proteins and noncoding (nc)RNA, and they have been implicated in the
propagation of several diseases including Alzheimer's and cancer. Our preliminary data show that canine VICs
from diseased valves produce different cell-free miRNA and EV-associated ncRNA signatures than cells from
normal valves. As such, the hypothesis underlying this proposal is that canine MVP can be leveraged to study
EV-signaling mediated factors that drive myxomatous valve degeneration, with the ultimate goal of
identifying and validating novel targets for early detection and therapeutic intervention. To accomplish
this, I will first complete the characterization of canine MVP at the histopathologic and molecular levels with a
direct comparison to human MVP, and then interrogate the impact of EV and ncRNA mediated signaling on VIC
gene expression profiles and function. These data will facilitate a more complete understanding of how EV-
mediated signaling influences the evolution of MVP and create a blueprint for incorporating spontaneous canine
MVP into the translational pipeline to optimize novel approaches for early detection and intervention. The rich
research environment at Tufts University and its partners including schools of Veterinary Medicine, Medicine,
Nutrition and Graduate Sciences, Tufts Medical Center, the Tufts Clinical Translational Sciences Institute, and
MIT ensure access to the resources and expertise necessary for successful completion of the proposed work.
My training in engineering and medical cardiology combined with guidance from my mentoring team bridging
expertise in human cardiology, comparative medicine, EV/ncRNA biology and bioinformatics/biostatistics makes
me well positioned to successfully transition to an independent clinician-scientist.

Public health relevance
PROJECT NARRATIVE Mitral valve prolapse (MVP), a common valvular heart disease with a prevalence of 2-3% in the human adult population, typically results in mitral regurgitation and congestive heart failure without surgical intervention. There are currently no induced models of disease that accurately recapitulate the pathophysiology and clinical consequences of MVP, precluding therapeutic advances. This project will credential naturally occurring myxomatous mitral valve disease in dogs as a large animal model for human MVP, provide additional insights into the role of extracellular vesicles and no-coding RNAs into the pathogenesis of MVP and create a blueprint for the development of novel medical interventions to mitigate progression of MVP.